Crosstalk of TGF-beta and TLR4 pathways in the trabecular meshwork

Elevated intraocular pressure (IOP) is one of the major risk factors for the development and progression of
glaucoma and is due to damage to the trabecular meshwork (TM). We have identified a novel molecular
pathway of TGFβ2 and toll-like receptor 4 (TLR4) signaling crosstalk involved in the development of ocular
hypertension and glaucomatous TM damage. We identified that the TLR4 signaling pathway is involved in the
regulation of the extracellular matrix (ECM) in the TM and activation of TLR4 can enhance the effect of TGFβ2-
induced glaucomatous phenotypes, while inhibition of TLR4 blocks the effect. We have identified both BMP
and activin membrane bound inhibitor (BAMBI) and fibronectin extra domain A (FN-EDA) as important
regulators of pathogenic TLR4 and TGFβ2 signaling in the TM. FN-EDA contains both integrin α4β1 and α9β1
binding sites which are known to regulate FN-EDA function. Recently integrin α4β1 was identified as a TLR4
co-receptor necessary for EDA-initiated activation of TLR4 in dermal fibroblasts. A20, an endogenous regulator
of downstream TLR4 signaling, has been identified as an important regulatory molecule in other fibrotic
diseases. Here we propose to determine the molecular mechanism of FN-EDA regulation of TLR4, determine
the role of endogenous regulators BAMBI and A20 on pathological TGFβ2-TLR4 signaling, and identify novel
therapeutic targets to prevent glaucomatous TM damage and elevated IOP. Our hypothesis is TGFβ2-TLR4
signaling crosstalk leads to pathological glaucomatous TM damage and elevated IOP, which can be
controlled by both therapeutic and endogenous regulators. We will address this hypothesis with 4 specific
aims: Specific Aim #1 will determine whether FN-EDA alters the TM morphology and function through TLR4
signaling. We will utilize B6.EDA+/+ mice which constitutively express only FN containing EDA and will analyze
the IOP profiles, TM morphology, and ECM makeup. Specific Aim #2 will determine whether the EDA-binding
integrins a4b1 and a9b1 are necessary for EDA activation of TLR4 signaling and ocular hypertension utilizing
primary human TM cells as well as a4 and a9 integrin floxed mice. Specific Aim #3 will determine whether the
endogenous negative regulators of TGFβ2-TLR4 signaling, BAMBI or A20, can block IOP elevation in mice.
We will overexpress Bambi (using Ad5.Bambi virus) or A20 (using Ad5.A20 virus) in the TM and determine
whether they can block Ad5.TGFβ2-induced ocular hypertension in C57BL/6J mice. Specific Aim #4 will
determine whether inhibiting FN-EDA expression can block IOP elevation in mice and in a human anterior
segment perfusion organ culture model (POC). Studies will use a fibronectin-binding peptide called FUD to
block EDA+/+-induced and TGFβ2-induced ocular hypertension. These studies aim to explore a novel pathway
involved in the development of glaucomatous TM damage. The data will be invaluable to the field of glaucoma
research and could provide new targets to lower IOP and further explain the mechanisms involved in the
development of glaucomatous TM damage.

Public health relevance
Project Narrative Glaucoma is a silent, underdiagnosed, costly and debilitating disease and the only treatment options for the disease include reducing elevated pressure in the eye. However, patients are sometimes resistant to current established treatments and it is crucial to identify therapies and develop new treatments for glaucoma that can directly save the visual neurons from dying. This study will examine the role of a newly discovered molecular pathway involved in the development of glaucomatous damage, which may lead to better treatments for glaucoma.